An end-to-end informatics framework to study Multiple Chronic Conditions (MCC)'s impact on Alzheimer's disease using harmonized electronic health records

Summary
The fragmented clinical data in EHRs and trials makes it hard to study the relationship between Alzheimer's
disease (AD) and multiple chronic diseases (MCC). This is because the data is often spread out across different
platforms and databases, making it difficult to get a complete picture. In addition, the data is often incomplete.
This can lead to gaps in research and missed opportunities to understand MCC’s contribution to AD progression.
To overcome these challenges, we will develop interoperable electronic health records (EHR) with an application
programming interface (API) that follows the standard data format, i.e., Fast Healthcare Interoperability
Resources (FHIR). Partnering with ACTIVE MIND, an interventional trial that examines the potential efficacy of
cognitive training (CT) in reducing dementia incidences, we will link, consent, extract and harmonize local EHRs
and other relevant health information from ~1,000 patients. We will develop ontology models and use them to
guide the natural language processing (NLP) models to distill, organize, and convert MCC and relevant concepts
into FHIR-accessible data. Using these data together with FHIR-mapped structured data, we propose a
demonstration project to develop novel missing data imputation and computational phenotyping models to stratify
heterogeneous subpopulations based on longitudinal MCC patterns to predict their AD onset risks.

Public health relevance
Narrative We will build an end-to-end system to convert electronic health records (EHR) to Fast Healthcare Interoperability Resources (FHIR) with integrated machine learning models to explore multiple chronic diseases (MCC)’s impact on Alzheimer's disease. Partnering with ACTIVE MIND, an interventional trial that examines the potential efficacy of cognitive training (CT) in reducing dementia incidences, we will develop a demonstration project to promote the use of interoperable health records in clinical research by identifying and stratifying patients with Mild Cognitive Impairment (MCI) who are at risk for developing Alzheimer's disease.